Characterizing the theranostic potential of DLL3-targeting agents in high-grade neuroendocrine carcinomas of the lung and prostate

PROJECT ABSTRACT
Small cell lung cancer (SCLC) and neuroendocrine prostate cancer (NEPC) are aggressive, high-grade
neuroendocrine neoplasms (HG-NENs) that often metastasize and do not respond well to treatment. Lung
cancer is the leading cause of cancer mortality worldwide and SCLC represents ~15% of lung cancers. Prostate
cancer is the most common solid tumor and the second-leading cause of cancer-related death among men in
the US. More than 20% of males with advanced prostate cancer eventually develop the highly aggressive NEPC
form. Both SCLC and NEPC are characterized by similar genetic (RB1 and TP53 loss) and phenotypic features,
as well as substantial intra-tumoral heterogeneity, which is implicated in therapeutic resistance. Identifying and
developing novel treatment targets and strategies for SCLC and NEPC is a critical unmet need. Delta-like ligand
3 (DLL3) is an antigen expressed on the cell surface of HG-NENs, whereas in normal tissues expression is
restricted to intracellular compartments, predominantly confined to the Golgi apparatus. DLL3 expression
correlates with neuroendocrine marker expression, RB1 loss, and aggressive clinical features. Based on the
over-expression of DLL3 in HG-NENs, we propose to utilize a DLL3-targeted radiolabeled monoclonal
antibody (mAb) for non-invasive diagnosis using PET imaging (89Zr-DFO-SC16.56 Ab) as well as for
image-based therapy (177Lu-DTPA-SC16.56). Our central hypothesis is that the overexpression of DLL3 on
HG-NEN lesions can be exploited for diagnostic and therapeutic purposes. To examine this hypothesis, our
phase I study will evaluate patients affected by HG-NENs with 89Zr-DFO-SC16.56 mAb PET/CT. Those who
exhibit sufficient target expression in at least 80% of the growing lesions will be treated with 177Lu-DTPA-
SC16.56. A key issue in such aggressive malignancies is the need to objectively determine treatment efficacy
by quantifying the radiation dose delivered to the target and assessing tumor radiosensitivity, which engenders
susceptibility to treatment. We will use molecular genomic tools to identify DLL3 transcripts and compare these
with known molecular signatures in blood and tissue that can define neuroendocrine and prostate cancer tumors
and correlate with response. The proposed study will investigate the safety and mechanistic basis of the efficacy
of radiotheranostics specifically targeting DLL3, a novel target for lethal malignancies for which currently limited
therapeutic tools exist. Our extensive experience in the development of DLL3-targeting PET agents and
validation in SCLC and NEPC models, along with our preliminary clinical PET data in SCLC and NEPC patients,
as well as our expertise in the ancillary use of molecular genomic tumor markers position us to successfully
complete the aims of this study.

Public health relevance
PROJECT NARRATIVE An antigen known as DLL3 is expressed on the cell surface of two rapidly lethal types of cancer (small cell lung cancer and neuroendocrine prostate cancer) and can be targeted with a radiolabeled antibody that delivers radiation to the site of disease. This antibody, SC16.56, can be used for both diagnosis (with PET imaging) and therapy, using a theranostic approach akin to a military tank equipped with radar and an intelligence report to survey a territory, as well as a missile to launch a targeted attack. We will evaluate this antibody’s safety and treatment efficacy in patients with these two aggressive cancer types and assess tumor response using imaging and molecular genomic tools.